Integrating and Expanding Clinical Research Networks

1. Increase the scope of RIOS Net activities to include new scientific questions, disciplines, and/or tools and approaches. 2. Increase participation of providers and communities to include appropriate training, within the network to include new sites, new patient populations and/or new investigators. 3. Collaborate with other clinical research networks to facilitate the communication and cooperation of RIOS Net with one or more additional networks. 4. Expand the RIOS Net information technology infrastructure and linkage capability.